Fluorescence Activated Cell Sorter

PROJECT SUMMARY/ABSTRACT
This proposal requests support for the purchase of a Becton-Dickenson (BD) FACS Melody cell
sorter. Fluorescence Activated Cell Sorters (FACS) sort through heterogeneous suspensions of
cells, typically obtained from enzymatic digestion of intact tissue or organs. The suspension of
cells is distributed into separate pools of homogeneous cells, based on their expression of
fluorescent proteins or their labeling with fluorescent antibodies directed at cell type-specific
proteins. FACS analysis is critically important for cancer biology, immunology, developmental
biology, heart, lung and blood studies, genetics, and other biomedical disciplines that involve the
analysis of cell type-specific responses that cannot be studied using tissue homogenates. The
instrument will be secured in a shared equipment core facility managed and supported by the
Stanley Manne Children’s Research Institute (SMCRI) at the Ann & Robert H. Lurie Children’s
Hospital of Chicago. Full time on-site technical experts in the core facility will train new users,
oversee the maintenance and calibration of the instrument, and provide user support during
normal business hours. The SMCRI will purchase a service contract for years 2-5, after the 1-
year warranty has ended, assuring long-term continued operation. Competitive recharge fees
will be charged to users, and used to support the purchase of supplies and service contracts.
The instrument will be used by eleven NIH-funded investigators (4 Major and 7 Minor) funded by
18 NIH awards within the SMCRI, as well as by junior faculty and trainees seeking to obtain NIH
funding. The SMCRI does not currently own a FACS analyzer, forcing its investigators to
compete for time on heavily subscribed instruments at neighboring institutions in Chicago.
Prioritized access to this instrument will therefore accelerate productivity of NIH-funded projects.
The highly automated functionality of this BD FACS Melody system will shorten the required
daily set-up time compared with older technologies, and also shorten the time required for
investigator training. These features will lower the costs to investigators and promote the
training of lab members and trainees. Finally, an Advisory Committee will oversee the operation
of the shared instrument, resolve any disputes that might arise with investigators, and assure
that the PI files the required reports to NIH in a timely manner.

Public health relevance
PROJECT NARRATIVE This proposal seeks support to acquire a state-of-the-art fluorescence activated cell sorter (FACS, Becton Dickenson FACS Melody instrument) for use by Stanley Manne Children’s Research Institute (SMCRI) investigators at the Ann & Robert H. Lurie Children’s Hospital in Chicago. FACS analysis is critically important for biomedical research in diverse disciplines related to human health, as it permits the collection of specific cell types from heterogeneous suspensions of cells, typically obtained through the enzymatic digestion of intact tissues, organs or tumors. SMCRI investigators currently must compete for access to heavily subscribed FACS instruments at neighboring institutions, so the acquisition of this instrument will accelerate research productivity of its investigators who study diverse biomedical processes that are central to human health and disease.